Large-scale evaluation of text features affecting perceived and actual text diffi

DESCRIPTION (provided by applicant): With increasingly more medical tests and treatments being available, more patients being diagnosed with chronic diseases that require life-long management, and increasing pressure on clinicians to see more patients in a limited amount of time, it is essential that patients learn and understand how best to take care of their health. Unfortunately, an estimated 89 million people have insufficient health literacy to do just that and the associated costs are estimated to be into the billions of dollars each year. Although there are many exciting opportunities to educate consumers, ranging from visualization to virtual environments, text is still the most efficient and cost-effective medium available to all groups in society. Unfortunately, existing writing guidelines, relying heavily on readability formulas, have not been shown to impact text difficulty or consumer understanding. Objectives The objectives of this project are therefore to address and overcome existing barriers in current readability research. We address barriers as follows: we will work 1) with representative consumers, not experts evaluating on behalf of consumers, 2) using a large sample with thousands of participants working in their own settings, not a laboratory study with few participants in an artificial environment, and 3) evaluate both perceived and actual difficulty of text, two variables often confounded in studies, 4) to discover features that can be automatically discovered in text so that difficulty checkers can be developed that allow clinicians to efficiently and effectively optimize their text without requiring study of guidelines or linguistics. Design The study will be conducted using modern technology and resources. Over a time period of two years, master and doctoral level students will design and conduct the studies together with the principle investigator. The study brings together insights from computational linguistics and information science applied to medical informatics. Starting from a linguistic perspective, we will we systematically list good candidates of text features that may influence understanding. We will look at features of grammar, semantics, and compositions of text. By using a modern market place, Amazon's Mechanical Turk, we can involve thousands of participants in the study. We will each pair-wise comparisons of the features, e.g., sentences with high versus low topic density. Using a within-subjects design, we will measure perceived and actual difficulty of each feature with multiple choice question-answering tasks.

Public health relevance
PUBLIC HEALTH RELEVANCE: Current health information is not attuned to the reading skills of consumers a situation that contributes to low health literacy and higher healthcare costs because of costly mistakes and unwise decisions. The proposed project will work with thousands of representative consumers to discover text features that influence perceived and actual difficulty of text. These features will lead to better writing guidelines and automated tools to help clinicians write health educational materials that are easier to understand and that are based on demonstrated impacts of the features on understanding. Current health information is not attuned to the reading skills of consumers a situation that contributes to low health literacy and higher healthcare costs because of costly mistakes and unwise decisions. The proposed project will work with thousands of representative consumers to discover text features that influence perceived and actual difficulty of text. These features will lead to better writing guidelines and automated tools to help clinicians write health educational materials that are easier to understand and that are based on demonstrated impacts of the features on understanding. __SpecificAimsTextDelimiter__ Specific Aims The goal of the proposed project is to conduct a large-scale evaluation with online health information consumers to systematically evaluate and discover features of text that are associated with text difficulty. We will start from a linguistic perspective to ensure a systematic evaluation of the different aspects involved in writing styles. We will make use of modern technology to involve thousands of participants in this study. We will demonstrate which features are associated with text difficulty, either perceived or actual difficulty. We will also make use of existing resources and technologies to ensure that our features are attuned for health text. We will ensure that any feature's detection can be automated so that this project may lead to the development of a time and cost efficient toolkit does not require linguistic knowledge by clinicians but can pinpoint difficult sections in text and suggest alternatives. The idea of a formula to evaluate text is admirable for the simplicity and efficiency it allows. It would be foolish to require clinicians to take linguistics classes before they could write for their patients. Therefore, any writing support, i.e., guidelines or formulas, should be easy to use but also be based on demonstrated difficulty levels of text. Text style affects difficulty and so influences understanding. However, the existing, popular readability formulas are based on simple word and syllable counts and are not calibrated for health information. The formulas assign a grade level to a text which represents the schooling required to understand the text. Much published work has focused on applying readability formulas on different texts without explicitly measuring understanding by consumers or patients. Moreover, most writing guidelines employ the formulas and emphasize that writing should be a 6th or 8th grade level. Adjusting educational materials and ad hoc writing to this level is difficult, time-consuming, and cumbersome for the physicians and others providing educational materials. The insistence on using these formulas is baffling, since few studies have shown a relationship between the grade levels and consumer understanding. Today, we have sophisticated tools and medically attuned resources at our disposal that can help evaluate text and associate it with actual understanding. If we are successful, we anticipate both short term and long term impacts. The short term impacts will be a data set showing impacts of text style on understanding and based on thousands of consumer tests. This data can be translated immediately into writing style advice. The long term impact is that the discovered features can be programmed as part of a difficulty checker, similar to MS Word's spelling and grammar checker. It will pinpoint difficult sections in a document during the writing process. This will become possible because we will constrain ourselves to features that can be automated. Our specific objectives are to address and overcome existing barriers in current readability research. We will do this by 1) systematically evaluating text features that may be associated with difficulty starting from a linguistic perspective, 2) measuring impact on perceived and actual difficulty, two independent variables often confounded today, 3) working with consumers instead of experts, and 3) limiting our features to those that can be automatically recognized for future implementation in text writing tools.